Mechanisms of sleep and sleep apnea

Summary – Overall Section
The overall goal of this Program Project is to identify and manipulate brain circuitry that mediates the
respiratory and arousal responses to hypercarbia and hypoxia, so that we may improve therapy for a variety of
hypoventilation syndromes including obstructive sleep apnea (OSA), opioid-induced respiratory depression
(OIRD), and obesity-hypoventilation syndrome (OHS). In the current PPG we used single cell RNA
sequencing (scRNA-Seq) to identify genetically specified cell subtypes in the parabrachial (PB)/Kölliker-Fuse
(KF) complex and the medullary raphe that are key components of this circuitry. We now seek to leverage this
information by using cutting-edge molecular tools to identify the functions of these cell types, their targets, and
the receptor mechanisms involved, and to define targets for rational pharmacological therapy of hypoventilation
syndromes. Project 1 will identify the cell types in the PB/KF that respond to hypoxia and hypercarbia,
characterize their physiological roles and how they are affected by morphine, and identify synaptic
mechanisms by which they activate their targets in mouse models of OSA and OIRD. Project 2 will examine
the role of orexin inputs to brainstem neurons in the PB/KF and medullary raphe that drive ventilation in OHS
and OIRD, their ability to augment respiratory function, and whether orexin agonists can improve breathing in
these mouse models. Project 3 will identify other forebrain sites that activate PB/KF respiratory neurons during
EEG arousal and the synaptic mechanisms that they use to augment respiration in OSA and OIRD models.
Project 4 will examine medullary raphe cell subtypes that augment respiratory motor responses during models
of OSA and OIRD, and whether orexin or TRH agonists can increase their responses and ventilation in those
models. Project 5 will test hypotheses from Projects 1-4 for new therapies for OSA and OIRD in human
subjects. In specific, it will test the effects of the orexin agonist danavorextan and the TRH agonist taltirelin, in
controls and OSA subjects at baseline and after morphine. These Projects will interact extensively with each
other, and with the Molecular Biology Core B and the Cellular Neurophysiology Core C, under the aegis of
Administrative Core A, to accelerate the advance of therapies for OSA, OIRD, and OHS from the bench to the
bedside.

Public health relevance
Narrative – Overall Section Inadequate breathing, or hypoventilation, such as in obstructive sleep apnea (OSA), opioid-induced respiratory depression (OIRD), and obesity-hypoventilation syndrome (OHS), can cause a variety of health problems, ranging from daytime sleepiness and cognitive impairment to cardiovascular problems and even death. The brain contains circuits that normally modulate breathing to avoid these outcomes, but they are not adequate to maintain normal breathing in these hypoventilation syndromes. We seek to better define the brain circuits that modulate breathing, find ways to augment these circuits to improve breathing in mouse models of OSA, OHS, and OIRD, and then test these therapies to improve breathing in human subjects with hypoventilation due to OSA and after administration of morphine.